Epigenetic Age Measures to Predict COVID-19 Symptom Progression and Severity

PROJECT SUMMARY The risk of fatality and/or severe complications due to COVID-19 infection is strongly age dependent. Data from the CDC suggests that those ages 85 and older have predicted mortality rates that is 100-fold higher than for those under the age of 50 and currently, 8 out of 10 COVID-19 deaths in the United States were in adults age 65 or older. While the exact etiology underlying this age disparity is unknown, evidence suggests that vulnerability may be due to changes that occur as a function of the aging process. This is further evidenced by the pattern of increased vulnerability among persons with pre-existing diseases of aging—cardiovascular disease, diabetes, COPD, chronic kidney disease, liver disease—suggesting that it isn't just chronological age that determines risk, but rather, biological age. In recent years, our group has helped develop some of the most robust biomarkers available, namely the epigenetic clocks. These measures estimate biological age in a sample based on DNA methylation levels at hundreds to thousands of CpG sites across the genome. Not only do epigenetic clocks track with age in diverse tissues and cell types, but discrepancies between epigenetic age and actual age have also been shown to predict risk of mortality and incidence of major chronic disease, including those which appear to be major risk factors for COVID-19. However, in order for these measures to be informative for assessing COVID-19 risk clinically, or in the general population, 1) they need to be re-optimized to capture the aspects of biological aging specific to COVID-19 susceptibility, and 2) advances in technology need to be made to ensure lower costs and rapid turnaround. This proposal aims to build on our team's multidisciplinary strengths to develop and validate a targeted, lab-developed, readily-available test to predict COVID-19 symptomology and mortality risk. If successful, this test will have widespread applications—from informing triage and treatment decisions in the clinic, to guiding social and pollical decisions when it comes to lifting “stay-at-home” orders for certain individuals.

Public health relevance
PROJECT NARRATIVE The risks associated with COVID-19 infection are highly age and health dependent, suggesting that biological aging may be a major determinant for symptom severity and mortality risk. Based on our previous work in developing biomarkers of aging, we propose to develop and validate a novel, rapid, and affordable COVID-19 test to predict long-term response to infection, based on DNA methylation.